Drosophila as a model to dissect the rise and role of calcium in egg activation.

Project Summary A differentiated, mature oocyte is “activated” to become totipotent and to begin embryo development through an increase in its cytoplasmic free Ca2+ levels. In mammals, this increase is initially induced by the fertilizing sperm, which stimulates release of Ca2+ from internal stores. However, recent studies have shown that subsequent Ca2+ oscillations that are essential for mammalian egg activation require influx of external Ca2+ from the environment into the oocyte, through as yet unknown channels and mechanisms. Although Drosophila had not been considered a good model for these processes because its eggs activate prior to fertilization, our recent work has shown that Drosophila egg activation also involves a local Ca2+ influx. This influx is followed by a wave of increased Ca2+ that sweeps through the egg cytoplasm, using mechanisms like those used by mammalian oocytes. We showed that the initial Ca2+ influx in Drosophila occurs at the oocyte poles, through mechanosensitive channels — most likely conserved channels in the TRP family. We propose to establish Drosophila as a new model for the Ca2+-based phase of egg activation. We will use this model to identify the channels that mediate sperm-independent Ca2+ influx and the conditions that cause Ca2+ channels to be open only at the egg poles. We will also determine whether the increased Ca2+ mediates the changes to the oocyte phosphoproteome that normally accompany egg activation, and whether the Ca2+ signal transducer calcineurin is required for these phosphoproteome changes. We expect the results of our studies to be generalizable to mechanisms in mammalian egg activation. Moreover, conserved proteins with Ca2+- dependent phosphomodifications will be candidates for future testing as markers for assessing human ART conditions, oocyte quality and aiding the diagnosis of infertilities that cannot respond to current ART methods.

Public health relevance
Project Narrative A fertilized egg must be able to initiate embryogenesis; disorders in this process cause infertility. The egg-to-embryo transition is generally mediated by an increase in the oocyte's cytoplasmic calcium levels that is now known to require entry of calcium into the oocyte, in mammals as well as in insects. Since the underlying mechanisms and immediate effects of the calcium influx are not understood in any organism, we propose to develop the Drosophila model to determine how calcium enters the oocyte and how this influx affects the oocyte's proteome; our results could provide markers to measure the quality of oocytes during assisted reproductive technology manipulations, or to diagnose certain infertilities.